The Desmosome-Keratin Intermediate Filament Network in Lung Epithelial Injury, Repair and Regeneration

The normal structure and function of the lung are maintained in homeostasis, and repaired and regenerated
following diverse injuries by region-specific stem and progenitor cells. Dysfunction or loss of lung stem cells is
believed to contribute to human idiopathic pulmonary fibrosis (IPF). Desmoplakin (DSP) is the most abundant
component of desmosomes, which are intercellular adhesive junctions found in epithelia. Previous genome-
wide association studies (GWAS) have identified a single nucleotide polymorphism (SNP), rs2076295 in DSP
intron 5, as a significant genetic variant associated with IPF. Recent studies revealed a transitional state in
alveolar type II progenitor cells (AT2) that is persistent in pulmonary fibrosis, including IPF. This transitional
state of AT2 is marked by elevated expression of Keratin 8 (K8), an essential component of the intermediate
filament (IF) cytoskeleton. The keratin IF cytoskeleton anchors to the desmosome through DSP binding,
forming a robust transcellular network that enhances mechanical resilience of epithelial tissues. Given the
critical roles of DSP and K8 in the desmosome-keratin IF network and their association with IPF, we seek to
explore the role of this network in lung injury and fibrosis. Preliminary data suggest that the desmosome-K8 IF
network serves dual functions in regulating apoptosis and differentiation of AT2, contextually linked to lung
injury and the niche stiffness. This model could resolve the contradictory results from earlier GWAS.
Specifically, low baseline DSP expression may predispose individuals to IPF by increasing AT2 susceptibility to
apoptosis post-injury. In contrast, higher DSP expression, triggered by increased niche stiffness, might induce
the transitional state of AT2 and inhibit their differentiation into alveolar type I cells (AT1), impeding lung
regeneration and promoting fibrosis. In this proposal, we hypothesize that the desmosome-keratin intermediate
filament network functions as a signaling platform, dynamically regulating the fate and state of AT2 cells in
response to lung injury and the mechanical properties of their niche. Specific aims are: (1) to determine the
mechanisms by which rs2076295 genetic variants regulate DSP gene expression and how reduced baseline
DSP expression increases the susceptibility of AT2 to apoptosis after lung injury; (2) to determine whether
matrix stiffness-dependent remodeling of the desmosome-K8 IF network regulates the transitional AT2 state
and the mechanisms involved; and (3) to test the therapeutic potential of targeting the mechanosensitive
desmosome-K8 IF network to reinstate AT2 regenerative capabilities and reverse persistent lung fibrosis in
mice.

Public health relevance
The deterioration or malfunction of lung stem cells is linked to the onset of idiopathic pulmonary fibrosis (IPF), the most prevalent and severe type of fibrotic lung disease. This study aims to unravel the molecular mechanisms that lead to the dysregulation of lung stem cells in pulmonary fibrosis. Insights from this research could lead to novel interventions and therapeutic strategies to prevent, manage, and possibly reverse fibrotic lung diseases.